Exploring Transcriptional Adaptation: Therapeutic Potential and Impact on Human Genetics

PROJECT SUMMARY/ABSTRACT
Mutations can lead to a wide-variety of genetic diseases. Recent sequencing studies, however, have identified
loss-of-function mutations, including within disease-relevant genes, in apparently healthy individuals, reviving
the interest in the concept of genetic robustness. In previous studies, we identified transcriptional adaptation
(TA), a novel mechanism through which cells can compensate for nonsense mutations by increasing the
expression levels of functionally related genes (e.g., paralogs, or the wild-type (WT) allele in case of
heterozygous mutations), in a manner dependent on mutant mRNA decay. We proposed a model whereby
following mutant mRNA degradation, mRNA decay intermediates are translocated back to the nucleus to
induce the upregulation of genes exhibiting sequence similarity. In my postdoctoral work, I identified ILF3 as
the key RNA binding protein modulating the transport of mRNA degradation intermediates from the cytoplasm
to the nucleus to induce TA. Additionally, I developed a screening strategy that identified ILF3-associated RNA
fragments, termed “trigger RNAs,” which can activate gene expression when transfected into cells. Trigger
RNAs hold the potential to be a new class of gene-augmenting therapeutic RNAs. In this K99/R00 application,
my first aim is to characterize the molecular characteristics of trigger RNAs, including their sequence and
structural requirements. These studies will enable better design of trigger RNAs, which can be beneficial for
both genetic and non-genetic diseases. My second aim is to explore the broader physiological role of TA by
investigating how TA influences the landscape of genetic diseases. Using a combination of functional
genomics, and population genetics data analysis, I aim to identify genes whose perturbation phenotype is
influenced by TA. Such genes could represent a class of genetic diseases that can be therapeutically targeted
through harnessing TA. In addition, the studies will allow for better understanding of how different variants
influence disease outcomes. My third aim will be to investigate the prevalence of dosage compensation to
heterozygous mutations, and understand how TA contributes to tolerance of heterozygous mutations in
mammals. My background in RNA biology and gene expression regulation, and having been a lead author in
the discovery of TA, puts me in a unique position to accomplish this proposal. During the K99 phase, I will be
supported by an outstanding team of mentors and advisors (Drs. Jonathan Weissman, Mark Daly, Olivia
Corradin, Konrad Karczewski and Harvey Lodish) with expertise in all aspects and methodologies required for
the completion of the proposed research. I will acquire new skills in population genetics and big data analysis. I
shall also promote my soft skills, including grant writing, leadership and management skills, through formal
coursework and training and institutional support from the Whitehead institute. The combination of mentored
support, training and data obtained in the K99 phase will act as a stepping stone towards achieving
independence as an investigator in the R00 phase and beyond, and leading a successful lab.

Public health relevance
PROJECT NARRATIVE Transcriptional adaptation (TA) is a novel genetic robustness mechanism through which cells can compensate for nonsense mutations by upregulating functionally-related genes, such as paralogs, in a manner dependent on mutant mRNA degradation. Recently, I characterized the molecular machinery underlying TA and discovered a new class of small RNAs, termed trigger RNAs, which can be engineered to activate gene expression. This proposal aims to further elucidate the molecular characteristics of trigger RNAs, explore the physiological role of TA and how it influences the landscape of genetic diseases and its therapeutic implications, and obtain a comprehensive understanding of the prevalence of dosage compensation to heterozygous mutations in mammals.